Tracing the timing of monozygotic twinning using somatic mutations.

Project summary
In this proposal, we aim to prove a hypothesis on the timing of monozygotic twinning that was first proposed in
the 1950s. The hypothesis states that the monozygotic twinning occurs at different stages during
embryogenesis, and that the timing can be inferred by the sharing of chorion/amnion at birth. While this simple
and intuitive hypothesis was incorporated into many textbooks, the scientific proof of the hypothesis is lacking.
The advent of whole-genome sequencing now allows us to use embryonic somatic mutations as molecular
barcodes of cellular lineages in early embryogenesis. We will use these somatic mutations to trace the
embryonic history of monozygotic twins with different degrees of chorionicity/amnionicity. We have shown that
detection of such embryonic somatic mutations is indeed possible on sequencing platforms. With our
bioinformatics pipeline, we hope to prove the hypothesis that the timing of monozygotic twinning is related to
the status of chorions/amnions shared by the monozygotic twins. In Aim 1, we will sequence twin families to
identify embryonic somatic mutations in monozygotic twins with varying degrees of chorionicity/amnionicity as
well as dizygotic twins. We will compare and validate the different pattern of embryonic somatic mutations in
different types of twins. In Aim 2, we will create a simulation model of the twinning event to understand the
genomic differences between the twins. This will allow us to estimate the timing of twinning with different types
of chorionicity/amnionicity. In Aim3, we will trace the twinning event at the single cell level by isolating single
cells from each twin to draw the cellular lineage trees of the twins.
Our study will emphasize the discordance between monozygotic twins and prove the commonly accepted
hypothesis that the chorionicity/amnionicity of monozygotic twins is correlated with the timing of the splitting
event of monozygotic twins. This will be the first study to comprehensively characterize the discordance of
monozygotic twins from a genomics perspective using embryonic somatic mutations. We will also show that
these embryonic somatic mutations can explain some of the discordance seen in monozygotic twins, and that
not all discordance in the twins should be referred to as non-genetic etiology. Tracing the embryonic somatic
mutations at the single cell level will help us precisely time the twinning event. Therefore, this study will
enhance our understanding of the basic biology of twinning and add another mechanism of explanation to
genetic discordance in monozygotic twins, which may also affect treatment and counselling options for the
monozygotic twins.

Public health relevance
Project Narrative Monozygotic twins are derived from a single fertilized egg, but are not 100% identical as most people assume. Subtle DNA differences exist between monozygotic twins that can be identified by whole-genome sequencing of the twins and parents. We will use these differences to infer the twinning events at the cellular level and how they might influence twin studies and health in twins.